Leadership and Administrative Core

The WF OAIC Leadership and Administrative Core (LAC) sets the scientific direction, optimizes
administrative and fiscal operations, and ensures the scientific integrity of the WF OAIC. LAC leaders, Drs.
Kritchevsky and Kitzman, will continue to use a proven collaborative leadership model that fosters operational
efficiency, high productivity, and innovative translational and multidisciplinary research focused on our theme,
“Integrating pathways affecting physical function for new approaches to disability treatment and prevention.”
The Specific Aims of the Core are to:
1. Provide overall scientific leadership and direction for the WF OAIC;
2. Efficiently manage the resources of the WF OAIC, in compliance with applicable institutional and
NIA/NIH policies; and
3. Increase WF OAIC’s impact by attracting new investigators, capturing new resources, and disseminating
and implementing findings in diverse settings.
The LAC will guide the direction of the WF OAIC by 1) providing administrative and budgetary support to the
WF OAIC in accordance with OAIC priorities; 2) seeking additional institutional resources to extend the scope
of its activities; 3) arranging scientific review of proposed pilot and development projects and REC candidates;
4) monitoring all OAIC activities for timely completion and achievement of goals and milestones, and
intervening to remove roadblocks or, if necessary, redirect resources; and 5) ensuring all OAIC-supported
activities follow federal and institutional rules, regulations, and guidelines for the responsible conduct of
research and participant safety. Under the LAC’s guidance, the cohesive and collaborative leadership and
experienced staff of the LAC will continue to foster a productive, cohesive, and dynamic OAIC.